Institute of Human Virology H3Africa Biorepository (I-HAB) ADMIN SUPPLEMENT

PROJECT SUMMARY/ABSTRACT
The Institute of Human Virology Nigeria (IHVN) H3Africa biorepository (I-HAB), has successfully
upgraded its practices to be ISBER compliant through an iterative quality assessment-based interaction
involving capacity building drawing upon Coriell’s proven models and graduated to be the W/Africa
H3Africa regional biorepository, During the COVID-19 pandemic, I-HAB lost 18 months of its planned
activities due to the disruption of services by the pandemic. So far, I-HAB has only successfully
received and aliquoted all DNA biospecimens from only one of the six H3Africa research projects that it
supports. Two of the projects deposited 67% and 86% while the rest of the three projects are below
50% submission; at only 0%, 17%, and 29%. The goal of this administrative supplemental submission
(1 JULY 2022 TO 30 JUNE 2023) is to ensure that all remaining biospecimens are deposited by
H3Africa investigators, aliquoted, and used in the final phase which is to distribute aliquoted
biospecimens and data to investigators from the wider scientific community whose application has been
approved by the Data and Biospecimen Advisory Committee (DBAC) to conduct high-quality genomics
and translational research in Africa using well processed, preserved and quality controlled and
redundantly protected human biological samples. To achieve this, I-HAB builds on its past successes to
address four specific aims. 1) Engage PIs to complete deposition and create sub-aliquots of primary
human biologic samples and genetic materials in compliance with GLP, ISBER guidelines, and QC
10% in line with H3Africa policies/ guidelines. 2) Populate, interrogate, and query the database
regularly to ensure that the online catalogue is up to date, interfacing regularly with other two regional
H3Africa biorepositories, the H3AfricaBionet team, and relevant stakeholders to review and brainstorm
on ways to address gaps during scheduled meetings. 3) Pilot processes for efficient distribution of high-
quality biological samples to the wider scientific community, based on Data and Biological samples
Access Committee approval and according to H3Africa policies and guidelines. 4) Strengthen I-HAB’s
business model as part of a long-term sustainability strategy. Working collaboratively with the other two
sister H3Africa biorepositories and the H3Africa Bionet, I-HAB continues to advocate for host
government and community support and pilot processes to make the regulatory and ethical process of
sharing samples and data easier. The strong institutional support through the expansion of the
biorepository to over 3times its size at IHVN’s new facility, the acquirement of a liquid nitrogen plant,
and the expansion of its clientele to investigators outside of H3Africa signals a sustainable future for I-
HAB.

Public health relevance
Narrative Following the disruption of the COVID-19 pandemic on the upgraded H3Africa W/Africa regional biorepository-I-HAB, this submission requests additional time to complete the proposed activity of the main grant to support the H3Africa Consortium and networks of African scientists to study genomics and environmental determinants of common diseases with the goal of improving the health of African populations. Since the human race originated in Africa and migrated to populate the world, studies of genes in African peoples are a powerful strategy for advancing human health globally. A biorepository based in Africa is a critical capacity to continue to promote this research by African scientists and the broader research community.